IMPACT Project 3 – Engaging clinical champions to improve clinical communication and health care use in healthcare systems

Widespread cancer prevention measures could reduce the incidence of future cancers in the US, but uptake among children remains far below national goals. To improve health care use, we developed Announcement Approach Training (AAT). AAT is a 1-hour communication workshop in which our physician facilitators train primary care teams to address the most critical problems in primary care: infrequent and ineffective recommendations for health care services. One of the most promising opportunities for scaling up AAT is to implement the intervention in healthcare systems, where most US pediatricians and family physicians now work. However, new approaches to delivering AAT will be needed to bring the intervention to scale effectively in these settings. Thus, as part of the P01 Program Project, “Improving Provider Announcement Communication Training (IMPACT),” Project 3 will enhance AAT to train systems' own clinical champions to deliver AAT, thereby building capacity for communication training. In Aim 1, we will identify opportunities to engage clinical champions in delivering AAT within their own healthcare systems. Working with 6 partnering healthcare systems, we will interview 24 champions to understand: anticipated problems with and facilitators to AAT delivery; opportunities to extend AAT activities to increase reach and sustainability; and preferences for receiving training on how to deliver AAT. In Aim 2, we will compare the impact of Champion AAT to Traditional AAT on health care use and clinical communication. Using Aim 1 findings, we will adapt our existing intervention package to train champions to deliver AAT to clinics in their own systems. In a 2-arm non-inferiority trial, we will randomize 40 clinics in our 6 systems to receive Champion AAT or Traditional AAT. We will compare interventions on the primary trial outcome, among children ages 11-12 years, at 12-month follow-up. We hypothesize that Champion AAT will be non-inferior to (i.e., as effective as) Traditional AAT. We will also compare our interventions on intermediate outcomes, including changes in workshop participants' communication, to identify mechanisms that may explain improvements in primary care uptake. In Aim 3, we will generate guidance to help healthcare systems compare and implement Champion AAT and Traditional AAT. We will compare our interventions on implementation measures to understand whether Champion AAT offers advantages, such as higher reach to primary care professionals, compared to Traditional AAT. Lastly, to unify Project 3 with other IMPACT projects, we will share data to support cost-effectiveness modeling in Project 4 and contribute the Champion AAT module to the P01-wide AAT Intervention Package. In this way, we will prepare our highly scalable intervention for national dissemination. Project 3 addresses the IMPACT Program Project theme by engaging clinical champions to build capacity for clinical communication interventions among primary care teams in healthcare systems.

Public health relevance
The proposed trial will test a new way to help healthcare systems improve primary care. We will train clinical champions to deliver communication workshops to primary care teams in their own systems. We expect that this champion-delivered intervention will improve health care use and build capacity for communication training in healthcare systems.